Administrative Core

The Administrative (Admin) Core is responsible for establishing, sustaining, and shaping the growth and
development of the Center. The Core oversees: (1) Center strategic planning, (2) scientific leadership and
oversight to ensure quality and productivity of the Signature, Exploratory (R34-size), and Pilot Feasibility (R03-
size) research projects; (3) logistical and administrative support to the Center components, and (4) facilitation of
a network of Consortium Partner stakeholders affiliated with the Center. Specific aims of the Admin Core are to:
1. Facilitate research on scalable and sustainable approaches to suicide prevention at justice intercepts
(defined as places where behavioral health services can intercept a justice trajectory to change
behavioral health [and justice] outcomes),1 addressing the #1 goal of the National Strategy for Suicide
Prevention (to integrate care across systems within communities).
2. Foster synergy among research disciplines and cores and support research projects
3. Oversee solicitation, review, and selection of 4-6 additional innovative pilot studies that capitalize on
center resources and extend the research program
4. Support training opportunities
5. Communicate the Center’s aims and activities
6. Oversee evaluation activities
7. Plan for sustainment of Center effects
The Admin Core is assisted in these activities by a leadership team that is experienced in the administration of
large, multi-component research programs, Center-dedicated administrative support, and a strong and diverse
group of collaborators and Consortium Partners. Consortium Partners include governmental, practice, policy,
and community partners (including individuals with lived experience and their families). The Center brings
together health system, justice system, and suicide prevention communities, constituencies who do not regularly
work together, to create novel solutions to a common problem. When system fragmentation is the crux of the
problem, bringing all the key players together is a crucial first step, as highlighted in our unifying Center model
(the Sequential Intercept Model). The Center will drive innovation by bringing together transdisciplinary expertise
which does not usually co-exist to create synergies that would not exist without the Center to address suicide
prevention at justice intercepts. The Center is tightly organized (Table 1), with timelines and milestones (Table
2), and a plan for accountability of and support provided to Center Cores and research projects. The goal is to
change practice and policy for justice-involved individuals in order to contribute to near-term reductions in the
U.S. suicide rate.